Evaluation of Report-Back Strategies for Long-term and Short-term Exposure Information in Rural Tribal Populations

The overall objective of this study is to optimize, validate, and evaluate the effectiveness of strategies for
reporting back environmental sampling results, with a focus on rural Native American populations and the
balance between real-time and delayed feedback for both acute and chronic exposure concerns. The bioethical
question of interest is: How does the information source (i.e., the messenger, format, and timing of education)
impact the effectiveness of report-back strategies in rural tribal populations? This project is innovative because
it addresses unanswered questions regarding the role that real-time exposure information plays in report-back
strategies, with application to rural Native American populations. Aim 1: Optimization of Real-Time Report-Back
Strategies for Rural Native American Research Participants. Previous work has involved environmental sampling
data (indoor/outdoor PM2.5 and indoor radon) at households of N. Arapaho tribal members. Half of the
participants received immediate exposure information from real-time, direct-reading displays while the other half
only received final, delayed feedback with average data. The question remains as to whether the report-back
strategies were as effective as desired. The hypothesis is that real-time exposure feedback will be more
acceptable for short-term health outcomes whereas delayed feedback will be more acceptable for long-term
health outcomes. Listening sessions and questionnaires will be used to evaluate prior approaches for both acute
and chronic exposures, with a specific focus on our bioethical question. Aim 2: Validation of Optimized Report-
Back Strategies for Rural Native American Research Participants. Based on the results of Aim 1, a series of
vignettes will be developed that target the report-back strategies of interest (e.g., real-time exposure data for
acute concerns, etc). These will be presented in 4-8 focus groups, with targeted discussions regarding the
messenger type, format, and timing of education. The hypothesis is that the report back strategy that will be
perceived as the most acceptable for all of the exposure scenarios will be in-person report-back by a tribal
member, with education both before and after sampling. Aim 3: Evaluation of the Implementation of Exposure-
Reduction Strategies from Report-Back of Environmental Exposures in Tribal Populations. Evaluation of the
developed report-back approaches for long term (radon) and short-term (PM2.5) exposure risks will occur in two
tribal populations: N. Arapaho and Utah Navajo. Reliability and generalizability will be tested to understand the
extent to which individual tribes have unique needs and where techniques are more universal. Effectiveness of
the strategies will be evaluated for the level of engagement with exposure-reduction activities, with a goal of
building local capacity for management of evaluation activities into the future. The hypothesis is that real-time
exposure feedback will result in more engagement with exposure-reduction strategies. The ultimate outputs of
this project will be validated guidance on the most effective strategies for reporting back environmental sampling
results, with a focus on increasing engagement with exposure-reduction activities in rural tribal populations.

Public health relevance
NARRATIVE The overall objective of this proposal is to optimize, validate, and evaluate the effectiveness of strategies for reporting back environmental sampling results to rural Native American populations, with a focus on the balance between real-time and delayed feedback for both acute and chronic exposure concerns. The bioethical question of interest is: How does the information source (i.e., the messenger, format, and/or timing of education) impact the effectiveness of report-back strategies in rural tribal populations? The ultimate outputs of this work will be a set of validated guidance on the most effective approaches, with a focus on increasing engagement with exposure-reduction activities in rural tribal populations, informing the broader research community, and helping build local capacity for the sustainability of evaluation activities in these populations.